A Multi-Ancestry Study of Gene-Lifestyle Interactions and Multi-Omics in Cardiometabolic Traits

PROJECT SUMMAR/ABSTRACT
Cardiometabolic diseases and risk factors, including hypertension, dyslipidemia, adiposity, and type 2
diabetes, represent a major public health burden that disproportionately affects diverse (non-European
ancestry) populations. Cardiometabolic traits are influenced by both genetic and environmental (lifestyle)
factors. Therefore, understanding interactions (GxE) between these factors could provide insights into
intervention, prevention and therapeutic strategies to reduce the burden of disease. Many genome-wide
association studies (GWAS) have made important genetic discoveries for many complex traits through
approaches based on “genetic main effects”. However, genome-wide interaction studies (GWIS) are still
limited. The objective of this study is therefore to identify novel genetic loci associated with cardiometabolic
traits through GWIS in large samples, to investigate gene-lifestyle interactions in the cardiometabolic trait loci,
and to characterize the molecular effects underlying the interactions by leveraging existing “Omics” data such
as DNA methylation, gene expression, and metabolites. By investigating genomic and lifestyle contributors to
health outcomes through their interactions across diverse populations and between sexes, our proposal
reflects the priorities of the Precision Medicine Initiative (PMI) whose focus is the interplay between
lifestyle/environment and genetics, with an emphasis on diverse populations.
We propose to evaluate gene-lifestyle interactions across diverse populations (European, African, Hispanic,
and Asian). Our recent progress with blood pressure, lipids, and dichotomized lifestyle factors (smoking,
alcohol consumption, physical activity, educational attainment, psychosocial factors, and sleep) encountered
limited statistical power. Therefore, we propose to vastly increase the power for GWIS with an ~10-fold larger
sample size and expand our focus to include other cardiometabolic traits (adiposity and diabetes traits),
quantitative lifestyle exposures (e.g., cigarettes per day), and aggregate Lifestyle Risk Scores as an overall
lifestyle risk factor for cardiometabolic health; evaluate the impact of identified interactions on clinical endpoints
(like coronary heart disease); assess the druggability of identified interactions; and characterize interactions
using multiple omics data. Our proposal includes our recent discovery studies (N~130,000), our recent
replication studies (N~252,000), and the addition of several new, substantially larger studies including the
Million Veteran Program (N~234,000), the UK Biobank (N~478,000), the Biobank Japan (N~160,000), and the
Study of Latinos (N~13,000), among others. The overall sample, including 912,000 European, 91,000 African,
33,000 Hispanic, and 231,000 Asian ancestry individuals, represents the most significant effort to date to
investigate interactions with an aggregate sample size of about 1.267 million. Findings can lead to new
diagnostic and therapeutic tools, contribute to precision care in the management of cardiometabolic disorders,
and provide insights for the PMI with the ultimate goal of enhancing clinical practice.

Public health relevance
PROJECT NARRATIVE The primary goal of the proposed research is to leverage existing genetic marker (GWAS) data in large numbers of studies across diverse populations to discover additional genetic loci for cardiometabolic traits, identify important gene-lifestyle interactions, and identify the molecular signatures that underlie the interactions. The investigation will be carried out in approximately 1.267 million European, African, Hispanic, and Asian Ancestry participants. Study results can contribute to enhanced clinical practice.